PROSPECTIVE STUDY TO DETERMINE THE EFFICACY AND SAFETY OF AZATHIOPRINE

The aims of the study is to determine whether azathioprine reduces the alloimmune response to valved allograft implantation in children who receive valved allografts at the time of pediatric heart surgery.